Developing the Next Generation of Leaders in Alcohol Research

Varying perspectives that include those of psychologists are essential to maximize scientific rigor, innovation, and generalizability in alcohol research. Investigators from the field of psychology are vital in the conduct of interdisciplinary alcohol research and evidence-supported treatment provision, and integral to the dissemination and implementation of novel behavioral, pharmacological, and combined treatment approaches for alcohol use disorders. Thus, the primary objective of the proposed alcohol research training program is to increase engagement and retention of psychology trainees in alcohol research careers. The EDAR program is aligned with NIAAA’s longstanding mission to support research education and the NIAAA Strategic Plan for 2017-2021. The specific aims of the EDAR program are to: 1) attract psychology trainees into internship programs with robust alcohol research training opportunities by providing individualized mentoring from near-peers and senior experts in the alcohol field, structured didactics focused on professional development, and financial support, 2) retain psychology trainees in alcohol research careers by engaging them in NIAAA-supported T32 programs and providing them the skills to become near-peer mentors, 3) examine the effects of the program on research engagement and career trajectories following program completion, and 4) identify barriers and facilitators to engaging and retaining trainees in alcohol research. Each year, we will recruit and retain cohorts of six outstanding psychology graduate students during the summer before internship application. The proposed EDAR program will provide two years of formalized didactic training and individual mentorship including: personalized feedback on internship and postdoctoral fellowship application materials, interview skill development, and financial support to offset trainee application and interview expenses. Thorough program evaluation will occur with direction from an expert panel of federally-funded alcohol researchers and educators in our Advisory Council to refine and improve the program and provide innovative data on potential barriers and facilitators to alcohol research involvement for trainees. The highly qualified leadership team, strong partnerships with senior alcohol investigators leading NIAAA-supported T32/T35 training programs, and a team of exceptionally qualified and dedicated faculty mentors will ensure that the proposed alcohol research education program is implemented with a focus on rigor and sustainability within a vibrant educational setting.

Public health relevance
The primary objective of this alcohol research training program is to increase the availability of skilled clinical scientists from the psychology field. We will achieve this goal by providing individual and group didactics and mentorship during the critical transition from clinical psychology doctoral training through clinical internship and NIAAA-supported postdoctoral fellowships. Implementing the proposed training program will help ensure that NIAAA remains a global leader in the development and dissemination of effective alcohol-related prevention and treatment efforts, and that it is equipped to fulfill its mission to meet the continuously evolving healthcare needs of the U.S. population.